Resilient Together for Dementia: A live video resiliency dyadic intervention for persons with dementia and their care-partners early afterdiagnosis

PROJECT SUMMARY
In this K23 proposal, I outline a comprehensive 5-year training program that will support my transition towards an
independent investigator focused on the development and rigorous testing of interventions for dyads (i.e., pairs) of persons
living with dementia (PWDs) and their informal care-partners, with an emphasis on early intervention. In this application,
I propose a significant and innovative proposal that is directly tied with my proposed training and career development
goals. Background: Alzheimer’s disease and related dementias (ADRD) produce a host of stressors for PWDs and their
spousal care-partners (SPs), who both experience substantial emotional distress after diagnosis. Emotional distress is
interdependent within dyads and – without treatment—becomes chronic and negatively impacts both partners’ health,
quality of life, and their ability to navigate the short and long-term challenges associated with ADRDs. Addressing
emotional distress early, when PWDs can still meaningfully participate, is an unexplored opportunity to prevent chronic
emotional distress and preserve quality of life for both partners. Specific aims and research design: I aim to develop the
first version of the live video Resilient Together for Dementia (RT-D) intervention and methodology via 1) interviews and
quantitative surveys (N=20) of PWD-SP dyads, with additional feedback from 2) focus groups with ADRD medical
stakeholders (N=4) (Aim 1). Next, I will explore, via an open pilot (N=5 dyads) with exit interviews and pre-post self-
report assessments, the initial feasibility, acceptability, and credibility of the live video RT-D and procedures, and to
further refine RT-D as needed (Aim 2). Finally, I will establish, via a pilot feasibility RCT of the RT-D versus control (N=
up to 50 dyads), the feasibility, acceptability and credibility of RT-D following predetermined benchmarks (Aim 3).
Findings will inform a hybrid efficacy-effectiveness trial through the R01 mechanisms and future studies extending this
work to include additional family members and other care-partners. Training and mentoring: My aims are supported by
3 training goals to develop expertise in: 1) qualitative and mixed methods assessment to inform intervention adaptation; 2)
specialty training in geriatrics and ADRD clinical care; 3) clinical trial methodology to facilitate dyadic intervention
development and refinement. I will obtain mentorship from an exemplary team led by my primary mentor Dr. Ana-Maria
Vranceanu, a clinical health psychologist with expertise in mixed-methods research and live video dyadic intervention
development, and my co-mentor Dr. Christine Ritchie, a geriatrician and palliative care physician with decades of work
improving the treatment of ADRD. My training goals are supported by 1) a team of expert mentors, 2) a rich institutional
environment at Massachusetts General Hospital and Harvard Medical School, and 3) targeted coursework, scientific
meetings, seminars and planned publications. Relevance to the NIA mission. This K23 is in line with NIAs priorities to
develop interventions to the maintain health and wellbeing and reduce the burden of ADRDs. Impact: I am a clinical
psychologist with expertise in couple and family interventions for neurological populations. The experience gained will
serve as the foundation for an independent career in dyadic interventions for ADRDs, with a focus on early intervention.

Public health relevance
PROJECT NARRATIVE The proposed study will establish the feasibility, acceptability and credibility of a novel live video dyadic resiliency intervention, Resilient Together for Dementia (RT-D), aimed at preventing chronic emotional distress and preserving quality of life among dyads at risk for chronic emotional distress early after a diagnosis of Alzheimer’s disease or related dementia (ADRD). Both persons living with dementia (PWDs) and their spousal care-partners experience high levels of clinically elevated emotional distress, which can become chronic without treatment and negatively impact the health, quality of life, communication, and care-planning of both partners. A tailored dyadic intervention delivered over live video to this at risk population during the window of opportunity when PWDs can participate has the potential to prevent chronic emotional distress and preserve quality of life for PWDs and their loved ones.